Enhance the CCSS biospecimen resource through characterization of clonal hematopoiesis among survivors of childhood cancer

ABSTRACT
The Childhood Cancer Survivor Study (CCSS; U24 CA055727; PI: Armstrong) is a multi-institutional, multi-
disciplinary collaborative research resource established to systematically evaluate long-term outcomes among
children diagnosed with cancer who survived five or more years from diagnosis. With the successful recruitment
and longitudinal follow-up of the cohort that includes survivors diagnosed and treated over three decades (1970-
1999), the CCSS is the world’s largest established open resource for survivorship research with 38,036 eligible
survivors available for investigation of late mortality, and 25,665 participants who have contributed health-related
and quality of life outcomes. The resource includes comprehensive annotation of treatment exposures, ongoing
longitudinal follow-up and an established biorepository from which genotype (single nucleotide polymorphisms
[SNP] array) and DNA sequencing of 8,380 survivors are available to investigators for identification of genetic
susceptibility for disease- and treatment- related late effects. The objective of the current supplement application
is to select survivors with an existing blood specimen to characterize clonal hematopoiesis of
indeterminate potential (CHIP) mutations through targeted deep sequencing.

Public health relevance
PROJECT NARRATIVE Survival rates for many childhood and adolescent cancers have improved at a remarkable pace over the past five decades. The Childhood Cancer Survivor Study (CCSS; U24 CA055727; PI: Armstrong) cohort has been the source of some of the most significant publications to date addressing the long-term mortality, morbidity and quality of life of survivors of childhood cancer. Understanding the risk for late effects of childhood cancer and its therapy provides the basis for health screening recommendations and interventions that can mitigate long-term health problems in this high-risk population.